Tumor Organoid-Mediated Drug Testing and Clonality Analysis in Peritoneal Surface Disease of Intestinal Origin

Project Summary
The overarching goal of this project is to develop a tumor organoid-based drug screening platform that quantifies
the differential drug responsiveness of tumor clonal heterogeneity to predict a patient’s therapeutic response
prior to treatment selection. Our research is directed at metastatic intestinal peritoneal surface malignancies
(IPSM), with a focus on colon and appendiceal cancers. These cancers are similarly treated and present clinically
with numerous spatially-distinct peritoneal metastases associated with different anatomic structures. The clinical
course of these cancers typically follows a path of chemoresistance, thus, ex vivo models that can identify drug
combinations and sequencing strategies able to mitigate chemoresistance would be of significant clinical value.
Innate and acquired chemoresistance results from genetic alterations that manifest within the tumor’s clonal
architecture and its changing clonal composition. In IPSM, we have observed distinct clonal variants among
spatially distinct lesions within the same patient indicating the potential for differential drug responses among
intrapatient lesions. Our central hypothesis is that a patient’s clinical response to chemotherapy is proportional
to the magnitude of the clonal response exhibited by the patient’s predominating cancer clones, which can be
assessed by chemosensitivity testing and clonality analysis using patient-derived tumor organoids (PTOs)
constructed from intra-patient lesions that reflect the patient’s metastatic clonal diversity. In Aim 1, we will
construct multi-lesion PTOs from a number of IPSM patients to investigate interactions between tumor clonal
fraction and PTO chemosensitivity. We will test the hypothesis that summative measures of chemo resistant and
sensitive clonal fractions will predict patient clinical treatment responses better than simple measures of organoid
cell viability. Furthermore, we will seek to identify genes in IPSM that are frequently mutated in chemo sensitive
and/or resistant clonal fractions across IPSM patients, and characterize candidate gene functions in colon cancer
cell line organoids and mouse xenograft models of colon cancer. In Aim 2, we will seek to extend the reach of
the PTO platform to include evaluation of immune checkpoint inhibitors (ICIs) which cannot yet be faithfully
modeled in human systems, and that have emerging roles in gastro-intestinal cancers, yet remain unexplored in
IPSM management. We will test the hypothesis that immune-enhanced PTOs (iPTOs) that preserve the patient-
specific homeostatic relationship between cancer cells and cytotoxic T cells (CTLs) can be used to model ICI-
induced cancer cell killing by tumor-reactive CTLs as well as to gain insight into tumor clonal alterations that
influence ICI responsiveness. We will use established murine immune-oncology models (CT26 and MC38) to
study tumor-CTL homeostasis in iPTOs, and to confirm ICI-response parity between ex vivo iPTOs and in situ
mouse tumors. We will confirm the involvement of antigen specific CTL-mediated cancer cell killing in ICI-treated
iPTOs. Finally, parallel to Aim 1, we will identify genes that are frequently mutated in ICI sensitive and/or resistant
clonal fractions of IPSM, and characterize their ICI-modulatory functions in immunocompetent mouse models.

Public health relevance
Narrative Chemoresistance of intestinal peritoneal surface malignancies is a considerable clinical problem with lethal consequences to patients. In this project we will develop a tumor organoid-based drug testing platform that models the genomic clonal composition of tumors and clonal drug response toward the prediction of clinical drug efficacy in patients.